Virtual chromatographic cytometry for in-line biomanufacturing process analysis

Project Summary/Abstract
Gene therapy is an emerging therapeutic technology that uses genes in targeted cells to prevent and/or
treat acquired disorders and inherited genetic diseases. The rapid advancement of human gene and disease
research has increased the demand for gene therapy and investment in the production of large-scale clinical
applications. However, the clinical potential of gene therapy is limited by the current manufacturing capability
of gene delivery products. Gene therapy biologics are mostly produced by harvesting viral vectors in
mammalian cell cultures, which is a delicate and intricate process that can be affected by many
environmental parameters. Inefficient monitoring and control of the viral production processes can lead to
various manufacturing defects such as cell instability, high impurities, difficult scalability, and low productivity.
Therefore, in order to develop efficient and robust biomanufacturing processes, comprehensive knowledge
and understanding of bioprocess dynamics are needed. This in turn necessitates the need to develop
capable analytical technologies to provide accurate and timely information on key bioprocess parameters
and quality attributes.
Physical Sciences Inc. (PSI), in collaboration with the University of Massachusetts Lowell (UML), proposes
to develop a novel in-line biomanufacturing process analytical technology tool. It enables real-time monitoring
of the biomolecules of host cells and their environment in large-scale bioreactors. The technology is based on
deep ultraviolet excited optical spectroscopic techniques that combine Raman scattering and
autofluorescence to differentiate cellular biomolecules including DNA and protein produced during cell culture
processes. An innovative spatially and temporally confined spectroscopy cytometry design will also be
adopted to efficiently distinguish intra-cellular biomolecules within the host cells from extra-cellular
biomolecules in surrounding media. A miniaturized optical probe will be designed that will inserted into an
agitated bioreactor for in-line cytometry measurements. In this Phase I program, a prototype cytometry probe
system will be designed, constructed, and evaluated by measuring and analyzing cellular biomolecules in
real-time during viral vector production bioreactor operations. During the Phase II program, the technology
will be improved, and its performance will be validated in different bioreactors using different culture
organisms. Successful development of this technology will support biotech R&D to improve the
understanding and monitoring of bioprocesses, which in turn will promote the development of new processes
for large-scale production of viral vector products for gene therapy applications.

Public health relevance
Project Narrative The focus of this project is to develop an optical sensing probe system that monitors cellular compounds in the biopharmaceutical production of gene therapy drugs. The real-time and in-line spectroscopic measurement data of cellular characteristics will promote the understanding and monitoring of cell-culture bioprocesses, and eventually promote gene therapeutic product manufacturing for clinical use.